Conditional and female lethal approaches for mosquito control

PROJECT SUMMARY
Gene drives (GDs) are a cutting-edge technology with the potential to improve human health, but gene
drives have many limitations that impede their useful application in the wild, particularly population suppression
drives. GD spread needs to outpace the fitness cost imposed on the population; otherwise, the GD will be
rapidly eliminated, and the population will persist. Many species have homing efficiencies that need to be
higher to overcome the high fitness load imparted on a population by population suppression drives. We aim to
develop new tools in Aedes aegypti, an important disease vector with intrinsically lower homing CRISPR gene
drive (HCGD) homing efficiencies, to improve the population suppression technologies to control this vector.
First, we will evaluate conditional and sex-specific lethal systems that can restrict lethal transgene expression
so they have a reduced fitness load on the population. These will include temperature-inducible (TI) systems
with gene drive elements (GDe) that have minimal fitness costs in the population until they are exposed to high
temperatures. We will also evaluate transactivating systems that are repressed in the presence of small
molecules or if binary until they are crossed. These approaches will generate female lethal effectors that are
confined in space and time, and, therefore, easier to drive into a population to achieve strong suppression.
Since it has already proven challenging to increase homing efficiencies in Ae. aegypti, we will focus on
reducing the formation and persistence of resistant alleles, another impediment to the drive. Over time,
imperfect repair mechanisms cause drive target sites to become resistant to drive cleavage. As these
cleavage-resistant sites accumulate over time due to increased repair errors and/or positive selection of the
resistance allele, the gene drive frequency reduces in the population and may ultimately go to extinction. We
will, therefore, develop a toxin-antidote (TA) drive, termed Home-and-Rescue (HomeR), to reduce the
accumulation of drive alleles and improve drive performance. We will study the impact of this design on
resistance allele formation, link the drive to a TI-female killing effector, and determine whether the drive can
spread to fixation and cause population suppression in population cage experiments.
Furthermore, we will leverage our work on the MGDrivE framework and its applications to explore the
population dynamics of these sex-specific and conditional-lethal drives in Ae. aegypti. This work will allow us to
better predict how a lethal HomeR drive will perform in wild populations and may elucidate essential
considerations for safety, efficacy, and future HCGD designs in Ae. aegypti. Therefore, combining conditional
lethal and sex-specific killing systems and a HomeR drive may overcome the low gene conversion rates in
Aedes aegypti to build novel and robust population suppression drives in this important disease vector.

Public health relevance
PROJECT NARRATIVE Homing CRISPR drives are cutting-edge technology that may be used to improve human health, but these systems have drawbacks that make it difficult to build robust and long-lasting population suppression drives in some species. To overcome major issues with population suppression homing drives in the dengue vector, Aedes aegypti, we aim to engineer and comprehensively evaluate novel female killing technologies and an improved Homing CRISPR drive termed Home-and-Rescue (HomeR). This approach will make female killing technologies easier to drive into a population, and the HomeR drive is designed to be resistant to a primary cause of gene drive failure, the accumulation of resistance alleles, and could therefore improve gene drive capabilities in this important disease vector.